Development Research Project (DRP)

Summary of Developmental Projects Program (DRP)
To ensure a continual renewal of high-quality scientific endeavors in the DF/HCC Kidney Cancer SPORE
and to fund efforts that will complement or enhance the overall quality of the DF/HCC Kidney Cancer
SPORE. In general, the DRP has funded established investigators. Based on our review, we will be mindful
of including more junior investigators. This Program will rely on the infrastructure created by the
Administrative, Evaluation, and Planning Core (Admin Core) to:
1. Solicit applications and/or identify novel kidney cancer research projects.
2. Evaluate these projects for funding.
3. Fund innovative developmental projects.
4. Re-evaluate projects for possible transition into full project status.
5. Evaluate the success of the program.

Public health relevance
Narrative: The Developmental Research Program of the DF/HCC Kidney Cancer Program is intended to attract established investigators to the field of kidney cancer in order to develop new ideas of investigation which may change the field or be developed into full projects in the SPORE